Training Program in Cellular and Molecular Biology

The mission of the Cell and Molecular Biology (CMB) program at Washington University in St. Louis is to
provide rigorous interdisciplinary training to a diverse group of PhD students in four related disciplines in order
to prepare them for successful careers in the biomedical workforce. It will provide students with the
fundamental concepts and methods of cellular and molecular biology, quantitative training, critical thinking and
communication skills, and other core competencies. The goal of our renowned and committed faculty is to
provide students with a firm foundation in rigorous research design via a holistic approach that includes high-
quality mentoring and fostering career development in a vibrant student-focused research environment. Our
training opportunities embody the breadth of cell and molecular biology to tackle challenges in human health
using systems from viruses and microbes to mammals. Over 100 core facilities support our research and
training mission, providing trainees with platforms to learn and utilize cutting-edge technology. The objective of
the CMB training program is to enable our students to pursue careers at the vanguard of scientific research
and education by helping them establish a broad scientific knowledge and professional skills, rich career
preparation guidance and resources, and an interdisciplinary network of colleagues. The CMB training program
will support 25 trainees for 2 years. Half of the trainees will be in year 2 and the other half will be in year 3 of
the program. These are pivotal years in the training path towards successful independent research. The CMB
program is highly integrated and will have a profound impact on the training of more than just our training
grant-supported students. Measurable outcomes include PhD completion rates, time-to-degree, program
reviews by internal and external faculty, longitudinal tracking of student development and self-efficacy in core
competencies. Most importantly, the pinnacle of success of the CMB training program is the ability of our
students to achieve their career ambitions in the biomedical workforce. This proposal builds on our successes
by introducing both proven and innovative educational features including five new initiatives: 1) Updated
curriculum, including a novel skills competency course (an outcome of our program evaluations and student-
need centered improvement processes); 2) Improved mentor training processes, including development of new
cross-cultural mentor training; 3) Holistic admissions and trainee appointment processes, including removal of
GRE requirement; 4) Enhanced training in rigor and reproducibility in core courses and thesis committee
meetings; 5) Earlier and more directed focus on career exploration and experiences. The CMB program
employs a continuous improvement process informed by internal and external reviewers and evidence-based
assessments to develop and implement effective new training methods.

Public health relevance
PROJECT NARRATIVE Most human diseases arise due to disruptions in basic cellular and molecular processes caused by mutations in one's DNA or the presence of a pathogen in one's body. Our program trains students in the core concepts and methods of cell and molecular biology, preparing them to uncover basic insight into the cell and molecular processes that normally control cell growth and development but that when perturbed can lead to diseased states. With better knowledge of these processes and more trained biomedical scientists in the workforce, we can improve our ability to detect, treat, and defeat many crippling human diseases.